SELECTIN/HEPARAN SULFATE INTERACTIONS IN ACUTE LUNG INJURY

(Adapted from the Applicant's Abstract) Previous studies have shown that heparan sulfate proteoglycans expressed on vascular endothelial surf aces may be relevant ligands for L-selectin on neutrophils and monocytes and P-selectin on platelets and endothelial cells. The long range objective of this project is to evaluate whether the interaction of human lung endothelial cell heparan sulfate proteoglycans with L- and P-selectins plays a role in post-traumatic lung injury. In addition, therapeutic heparin can block L- and P-selectin dependent interactions in vitro, suggesting that natural and chemically-modified forms of heparin might be used to treat acute lung injury. The specific aims are to: (1) determine the expression of L- and P-selectins and their ligands in human pulmonary tissues in the setting of post-traumatic acute lung injury; (2) Examine proteoglycan expression under inflammatory traumatic acute lung injury; (3) Study the role of selectins and the effect of hind-limb ischemia-reperfusion; (4) study the structural requirements for the interactions of unfractionated heparin, low molecular weight heparins, and heparin fragments with L- and P-selectins.